The National Center for In-situ Tomographic Ultramicroscopy (NCITU)

Project Summary/Abstract
The National Center for In-situ Tomographic Ultramicroscopy (NCITU), based at the New York
Structural Biology Center, provides user access and service towards preparing specimens for
direct visualization of macromolecular associations and organization, particularly in native cells.
A highly qualified technical team provides direct hands-on service, guidance, and assistance to
ensure that samples and grids are prepared with the highest quality and in the shortest time
possible.
We are requesting funds to purchase equipment to upgrade and expand our computational
resources and upgrade our Thermo Fisher Scientific (TFS) Aquilos2 for correlative light and
electron microscopy (CLEM) work. These upgrades will benefit all users of NCITU by increasing
the capability and capacity of these instruments.

Public health relevance
Project Narrative Cryo-Electron Tomography (CryoET) has unique capabilities for directly visualizing macromolecular associations and organization in native cells. NCITU will provide nationwide access to state-of-the-art equipment, technical support, cross-training, and methods development towards disseminating new services to enable and streamline specimen preparation for cryoET.